Evaluating promising progestins through surgical window trials in women newly diagnosed with endometrial cancer

Project 4. Evaluate Promising Progestins in Endometrial Cancer Through a Rotating Umbrella Surgical
Window Trial
Abstract
Progestins are the most commonly employed hormonal agents to treat and to prevent endometrial cancer
and atypical endometrial hyperplasia (EC-AEH). There is a critical need to improve hormone therapy for EC-
AEH given the substantial increase in incidence and mortality associated with this common malignancy and the
increased lifetime risk of breast cancer associated with progestins in current use. In addition, there are more
than 20 progestins routinely prescribed for contraception and hormone replacement therapy, but few have been
evaluated for efficacy in the EC-AEH. The overall goal of this project is to test promising progestins in the clinical
setting in order to identify better treatment strategies for EC-AEH patients. We will employ an innovative clinical
trial platform paired with in depth molecular analyses of clinical samples to identify an improved “next generation”
hormone treatment as well as biomarkers of response in two aims: Aim 1. Perform an adaptive, master protocol,
surgical window of opportunity rotating umbrella trial to assess the effectiveness of progestins in tissues from
women with newly diagnosed endometrial cancer or atypical endometrial hyperplasia. Substantial population-
based data from the Women’s Health Initiative and other sources indicate that medroxyprogesterone acetate
(MPA), commonly used in previous cooperative group trials, is not the ideal compound for women with EC-AEH.
Although MPA is effective in the initial treatment of approximately 60% of EC-AEH patients, it is potentially an
agonist with respect to breast epithelial proliferation and has been associated with an increased risk of breast
cancer. We hypothesize that the most efficacious and safe progestin is one that inhibits cellular proliferation in
gynecologic epithelia and does not induce proliferation in breast epithelia. We will rotate additional FDA-
approved or commonly used progestins into the umbrella trial based upon preclinical data from Projects 1, 2,
and 3 demonstrating effectiveness in inhibiting EC-AEH cancer models while not inducing proliferation in breast
models. Aim 2. Establish biomarkers and molecular signatures of progestin efficacy in patients with endometrial
cancer. We hypothesize that protein and gene expression patterns from patient specimens will reveal biomarkers
of progestin efficacy. We will identify expression biomarkers predictive of outcome by RNA-seq using pre-
treatment surgical samples and markers of efficacy by comparing pre- and post-treatment surgical samples from
the window trial in Aim 1 in combination with additional patient samples and models that we have collected. We
will also viably isolate tissue from hysterectomy specimens from patients on the trial in Aim 1 and collaborate
with Project 1 to create and test organoids for progestin activity. The expected outcome of these studies is to
confirm the effectiveness of one or more progestins identified from Projects 1, 2, and 3 in a novel clinical trial in
women with EC-AEH. We will study only those compounds that show a strong response in the endometrium
without increasing breast cancer development in preclinical models. We will also determine the best biomarkers
of cellular response as well as the most efficacious agent to study in a future clinical trial.

Public health relevance
Project Narrative – Project 4. Evaluating Promising Progestins in Endometrial Cancer Through a Rotating Umbrella Surgical Window Trial Every day, millions of women take synthetic hormones called progestins, a treatment for contraception, hormone replacement therapy and to reverse precancerous uterine conditions. With so many women exposed over decades, it is very surprising that many compounds have not been fully tested, neither for long-term side effects nor for mechanism(s) of action. The goal of Project 4 is to “Evaluate Promising Progestins in Endometrial Cancer Through a Rotating Umbrella Surgical Window Trial” to identify effective and safer progestins for the prevention and treatment of endometrial cancer.